PRE AND POST TRANSPLANT DST/CSA IN NON HLA IDENTICAL DONOR KIDNEY TRANSPLANTS

This study is designed to assess whether donor specific transfusions of whole blood given to the recipient before and after transplantation will help the recipient retain a well functioning graft and reduce or stop the use of prednisone.